EFFECT OF AGING ON ENERGY EXPENDITURE AND REQUIREMENTS OF HEALTHY WOMEN AND MEN

Using stable isotope techniques energy requirements will be analyzed and the interrelationships between body composition and key metabolic parameters will be explored.